The role of epigenetics in RPE heterogeneity with early AMD

Summary
The NEI AMD Pathobiology group concluded that identifying all of the pathogenic signals, prioritizing their
contribution relative to one another, and establishing when these signals are pathogenic will lead to effective
treatment for each AMD stage. Because preventing or curing early AMD will eliminate the burdens of advanced
AMD and reduce its financial burden, this proposal will focus on early AMD. Cellular heterogeneity is a well-
recognized phenomenon. While ordered heterogeneity is protective, stress causes disordered heterogeneity
that induces disease by aggressive subclones, even if comprised of a limited number of cells. Retinal pigment
epithelium (RPE) heterogeneity is well recognized in early AMD, but its pathogenic role is unexplored.
The epigenome mechanistically links environmental exposures with the transcriptome to influence biological
processes, and epigenetic changes vary across individual cells to cause pathogenic cellular heterogeneity.
Smoking, the highest environmental risk factor for AMD, is a powerful epigenetic inducer in part, due to the
altered expression of chromatin modification enzymes that can reprogram the transcriptome to disrupt multiple
cytoprotective pathways, a fundamental characteristic of a complex disease like AMD. Using ATAC-seq and
RNA-seq, we previously linked reduced chromatin accessibility in promoter regions of genes with the RPE
transcriptome in early AMD eyes, implicating the RPE as a driver of early AMD. Furthermore, iPSC-RPE cells
treated with smoke had chromatin accessibility profiles similar to the RPE from early AMD eyes. While
valuable, this global approach does not define RPE heterogeneity or the impact of heterogeneity on RPE
functions related to AMD pathobiology. The objective is to define RPE heterogeneity in early AMD due to
reduced chromatin accessibility from smoking by addressing the hypothesis that pathologic RPE subsets
contribute to early AMD through transcriptome changes induced by epigenetic or genetic alterations. SA1.
Define pathogenic RPE heterogeneity by regional location in aging and early AMD by chromatin accessibility
and transcriptome modifications. ScRNA-seq and scATAC-seq will be used on the RPE from the macula and
periphery from aging and early AMD genotyped globes, and chromatin accessibility and pathologic pathways
from cellular subsets will be visualized by ATAC-see and immunohistochemistry. SA2. Determine the extent
that RPE heterogeneity i) develops due to chromatin accessibility and transcriptional heterogeneity with aging
or smoking, and ii) impacts RPE function in a model of early AMD. ScATAC-seq and scRNA-seq will be used
to assess chromatin accessibility and transcriptional RPE heterogeneity in wild-type (littermates), HDAC11-/-,
and WT mice treated with HDAC11 inhibitor Mocetinostat exposed to chronic cigarette smoke. The spatial
distribution of RPE heterogeneity will be identified using immunofluorescence of biomarkers of cellular subsets
and ATAC-see and impact on RPE function will be assessed.

Public health relevance
Project Narrative Age-related macular degeneration (AMD), the most common cause of blindness among the elderly and without a cure for early disease, is initiated by retinal pigment epithelial (RPE) degeneration. Variation in the RPE degeneration is well recognized in early AMD, but how it causes AMD is unknown. This proposal will determine the extent that RPE heterogeneity causes the conversion from aging to early AMD.